Training in Multi-Modality Molecular and Transitional Cardiovascular Imaging

This is the revision of a second competitive renewal of a currently funded T32 grant that received a very
favorable initial review. This grant provides post-doctoral training in multi-disciplinary multi-modality molecular
and translational cardiovascular imaging for highly qualified fellows holding either a MD or/and PhD, in
preparation for academic careers as independent investigators in the highly clinically relevant field of
cardiovascular imaging and image guided intervention. As imaging technology and molecular medicine
advances, increasingly complex questions often arise requiring the convergence of perspectives from multiple
disciplines. The future of cardiovascular imaging will most likely be practiced by integrated multidisciplinary
teams with diverse areas of expertise. The goal of this research training program is to provide the necessary
skills needed to work in this new multi-disciplinary investigative environment. Applicants will be recruited from
both clinical and basic science departments, with attention paid to recruitment of female, minority, disabled,
and disadvantaged candidates. We will continue to select and enroll applicants to maintain support for 6 post-
doctoral fellows each year, with an equal balance of physicians and scientists. We have added a new pathway
that focuses on image-guided therapy, and have expanded the image analysis pathway to include specific
training in machine and deep learning provided by the recently established Translational Image Analysis and
Machine Learning (TIAML) Center and partnering with data science center at the university. Post-doctoral
fellowship training will be 2-3 years in duration. There will be four primary research focuses in the post-doctoral
training, 1) cardiovascular molecular imaging, 2) cardiovascular imaging technologies and analyses, 3) image
guided therapy, and 4) translational cardiovascular imaging. The primary faculty for this program are from the
Department of Biomedical Engineering of the Yale School of Engineering and Applied Sciences and from
multiple departments within the Yale School of Medicine, including: Internal Medicine (Section of
Cardiovascular Medicine), Radiology & Biomedical Imaging, and Surgery. The faculty sponsors have been
selected based on extramural support, research productivity, and commitment to multi-disciplinary training.
Each trainee will be assigned a primary preceptor in the basic sciences and engineering or clinical research
and co-mentor with complementary expertise. Trainee progress will be monitored by individual mentors, the
trainee’s advisory committee, and the Program Directors. Drs. Sinusas and Duncan will co-manage the
program to assure a balanced and integrated experience in the relevant clinical and engineering sciences. We
have also established a more formal relationship between our T32 training program and the Vascular Biology
T32 training program within the section of Cardiovascular Medicine and will establish an annual research
retreat with fellow presentations of research in progress. This retreat should help to better integrate basic,
translational and clinical research within the Section of Cardiology and other participating departments.

Public health relevance
Cardiovascular disease remains the major cause of morbidity in the US with the cost of care exceeding $555 billion in 2015 and as such, there has been a shift in emphasis from treatment of disease to the prevention of disease. Prevention of cardiovascular disease necessitates early detection and risk stratification, which may be facilitated by molecular and other multimodality imaging approaches allowing for a more precise and personalized approach to the evaluation and management of cardiovascular disease. For molecular imaging to emerge as a routine part of clinical practice, appropriate education within the cardiovascular physician community and training of a new breed of physicians and scientists is needed.